The role of BRSK1, a PKC epsilon substrate, in behavioral and physiological responses to ethanol

Project Summary/Abstract:
Alcohol use disorder effects numerous people around the world and creates an enormous cost on society. The
pharmacological treatments available are limited and modestly effective. One mechanism by which alcohol
perturbs brain function is by altering synaptic transmission by altering the release probability of synaptic
vesicles. The molecular mechanisms underlying this action are not known. Protein kinase C epsilon (PKCε)
regulates both synaptic vesicle release and alcohol consumption in mice. Alcohol enhancement of inhibitory
neurotransmission in the central amygdala (CeA), which is implicated in regulating alcohol consumption, is a
process dependent on PKCε, and inhibition of PKCε in the CeA decreases alcohol consumption in mice. It is
not known how PKCε regulates synaptic vesicle release. Brain serine/threonine kinase 1 (BRSK1) is
phosphorylated by PKCε, colocalizes with pre-synaptic markers, and increases the release probability of
synaptic vesicles. The objective of this project is to determine the role of BRSK1 in behavioral and
physiological responses to alcohol and its relation to PKCε signaling. Based on preliminary evidence, the
hypothesis is that BRSK1 via PKCε signaling mediates alcohol-induced GABA release in the CeA, limits
sensitivity to ethanol intoxication, and promotes ethanol consumption and reward. This project will utilize
several behavioral and pharmacological methods to determine the role of BRSK1 in behavioral responses to
alcohol (Aim 1). The role of BRSK1 in alcohol-enhancement of inhibitory neurotransmission in primary neurons
from the central amygdala will also be examined (Aim 2). The results of this project will increase understanding
of the downstream signals that mediate PKCε regulation of alcohol related behaviors and alcohol’s
enhancement of inhibitory transmission in neurons of the CeA. This project may also provide evidence for
BRSK1 as a drug target for the development of novel treatments for alcohol use disorder.

Public health relevance
Project Narrative Protein kinase C epsilon (PKCε) mediates several behavioral and physiological responses to alcohol but the downstream signals that mediate its effects are underexplored. Proposed experiments will investigate the role of a newly identified PKCε substrate, BRSK1, in these behavioral and physiological responses to alcohol. This information could lead to identification of BRSK1 as novel therapeutic target for alcohol use disorder.